PREVALENCE OF METABOLIC BONE DISEASE/SHORT BOWEL SYNDROME

The purpose of this study is to determine whether children with short bowel syndrome who no longer require parenteral nutrition have decreased bone mineral density measured by dual energy x-ray absorptiometry, when compared to age-matched controls. Dietary intake of calcium and phosphorus, and serum levels of calcium, phosphorus and vitamin D metabolites will also be assessed.